Mechanisms of Type 1 Diabetes in the Autonomic Control of Circulation During Exercise

Project Summary/Abstract
Although consistent physical activity is routinely prescribed to control hyperglycemia associated
with type 1 diabetes (T1D), individual bouts of physical activity may increase the likelihood of
evoking dangerous cardiovascular responses (i.e., heart attack and/or stroke). The long-term goal
of this project is to elucidate mechanisms of autonomic dysfunction of cardiovascular control dur-
ing physical activity to improve health and reduce mortality in those with T1D. The overall objec-
tive is to determine the roles of P2X3Rs and ASIC3 on the exaggerated BP response to physical
activity in males and females who are differentially afflicted by T1D and cardiovascular disease.
The central hypothesis is that the effects of both P2X3Rs and ASIC3 on thin fiber muscle afferents
contribute to the exaggerated exercise pressor reflex in T1D rats, an effect that changes with the
pathophysiology of the disease. The rationale for this project is that understanding mechanisms
of autonomic dysfunction of cardiovascular control, which present in response to physical activity,
will lead to treating the temporal pathophysiology of T1D, thereby ameliorating risk of adverse
cardiovascular events. The central hypothesis will be tested with three specific aims: 1) Determine
the effects of metabolically sensitive P2X3Rs and ASIC3 on the altered exercise pressor reflex in
T1D rats at different phases of the disease; 2) Determine the effects of metabolically sensitive
P2X3Rs and ASIC3 on group III and IV afferent activity in T1D rats at different phases of the
disease; 3) Determine the expression patterns of P2X3Rs and ASIC3 in the DRG neurons of T1D
rats at different phases of the disease. For Aim 1, cardiovascular responses to muscle contraction
will be measured in T1D rats before and after blocking or stimulating ASIC3 and P2X3Rs. For
Aim 2, group III and IV afferent activity during muscle contraction will be measured in T1D rats
before and after blocking or stimulating ASIC3 and P2X3Rs. For Aim 3, the location and expres-
sion of ASIC3 and P2X3Rs on hindlimb DRG neurons will be determined using various biochem-
ical techniques. The research proposed in this application is innovative because this will be the
first study to determine the changing interactive effects of receptors and channels evoking reflex-
ive blood pressure responses during exercise in both male and female T1D rats. Additionally, this
study will be the first to analyze sex differences in blood pressure responses to exercise in T1D.
The proposed research is significant because it will provide an initial understanding of possible
mechanisms responsible for evoking the exaggerated exercise pressor reflex in T1D.

Public health relevance
Project Narrative The proposed research is relevant to public health, as well as the mission of NIHLBI, because it will ultimately inform treatment options to decrease the risk of having an adverse cardiovascular event during physical activity in individuals with T1D. Upon successful completion of the proposed project, we expect our contribution to be an initial understanding of possible interactive mechanisms responsible for evoking exaggerated blood pressure responses in those with T1D, and whether sex differences play a role.